Animal Models & Histology Core

Project Abstract
The goal of the Center for Redox Biology and Cardiovascular Disease is to improve the infrastructure for junior
and senior investigators and to provide mentoring for the junior faculty members so that they become more
competitive for independent NIH funding. The Animal Models & Histology Core B, led by Dr Karen Stokes, will
provide services to both the COBRE members and others at our institute and nearby institutes at which our
cardiovascular researchers have collaborations. Dr Hugh Price will lead the Histology and Genotyping
Subcore. This will build upon current existing services to provide cardiovascular-related pathology analysis and
add a new genotyping service. The Cardiovascular Phenotyping Subcore, led by Dr Shenu Bhuiyan, will
provide capabilities to characterize the disease models. Specifically, a Peri-med PSI system will provide the
ability to non-invasively image and measure blood flow, a VisualSonics Vevo 3100 Ultra High Frequency
Ultrasound will allow study of cardiac function, and a TSE telemetry system will be used to continuously record
blood pressure, activity, temperature, and biopotentials. Full-time research technicians will provide the services
or train the lab personnel to perform their experiments using the available technologies. This core will help
animal models generation, and provide cutting edge phenotypic and pathological analysis to maximize the
competitiveness of our junior faculty for future funding in the area of redox regulation of cardiovascular
disease.